Sustaining AFRPS Implementation and Advancing Mutual Reliance: Enhancing Animal Feed Regulatory Oversight and Collaboration in Louisiana

Project Summary/Abstract
Title: Animal Food Regulatory Program Standards (AFRPS) Implementation Development
and Maintenance, with Mutual Reliance Initiatives
FON: PAR-25-003
Clinical Trials Not Allowed
The Louisiana Department of Agriculture and Forestry (LDAF), Office of Animal Health and Food
Safety (AHFS), Feed Program Division seeks continued funding to maintain full implementation
of the Animal Feed Regulatory Program Standards (AFRPS) and expand participation in mutual
reliance initiatives with the U.S. Food and Drug Administration (FDA). The LDAF Feed Program
achieved full AFRPS implementation as verified by FDA during a February 2024 audit and is
preparing for its next audit in May 2025. The program is committed to advancing animal food
safety through effective regulatory oversight, collaborative planning, and strong federal-state
integration. LDAF will maintain and strengthen its inspection program by continuing to perform
FDA contract inspections and increasing the number of non-contract inspections conducted in
alignment with Compliance Program Guidance Manual (CPGM) 7371.000. These inspections will
follow risk-based principles and adhere to current Good Manufacturing Practices (cGMP) and
Preventive Controls for Animal Food (PCAF) requirements. To support FDA work planning, the
program will provide firm inventories categorized by risk and participate in work-sharing and
data-sharing initiatives. LDAF will continue to enhance its ability to share regulatory data with
FDA, supporting a unified regulatory framework and promoting efficient oversight. The Feed
Program will collaborate with the LDAF Agricultural Chemistry Laboratory by assigning trained
personnel to collect official samples. This effort will support timely laboratory analysis and ensure
coordinated follow-up for samples submitted under the Laboratory Feed and Fertilizer
Monitoring (LFFM) program. LDAF will expand its State Auditor Program by advancing two staff
members into Phases 2 and 3 of FDA’s state auditor development pathway, with a training audit
and verification audit scheduled for August 2025. This will enhance Louisiana’s ability to conduct
independent program audits and support mutual reliance outcomes. The program will also
increase outreach efforts by identifying venues and developing educational materials focused on
AFRPS, cGMP, and PCAF regulations. These materials will promote industry awareness and
encourage voluntary compliance among feed manufacturers and stakeholders. Regular quarterly
meetings with FDA will continue to support collaboration on enforcement strategies, performance
evaluation, policy review, training needs, and mutual reliance objectives. Through sustained
AFRPS conformance and ongoing partnership with FDA, LDAF aims to enhance regulatory
consistency, reduce duplication, and strengthen public and animal health protection across
Louisiana and the nation.

Public health relevance
Project Narrative Project Title: Animal Food Regulatory Program Standards Implementation Development and Maintenance, with Mutual Reliance Initiatives Applicant: Louisiana Department of Agriculture and Forestry (LDAF) Funding Opportunity Number: PAR-25-003 Clinical Trials Not Allowed The Louisiana Department of Agriculture and Forestry (LDAF) seeks continued funding to maintain full conformance with the Animal Feed Regulatory Program Standards (AFRPS), enhance mutual reliance with the FDA, and improve oversight of the state’s animal feed industry to protect public and animal health. The program will conduct risk-based inspections, expand sampling and laboratory coordination, strengthen auditor qualifications, and increase stakeholder outreach while aligning with federal standards under FSMA. These efforts will sustain AFRPS conformance, improve regulatory efficiency, and advance national food safety goals through strengthened state-federal collaboration.